Toward high spatiotemporal resolution models of single molecules for in vivo applications

Project Summary
Background and Knowledge Gap: Unraveling life's intracellular processes at single molecule (SM) spatiotem-
poral scales is critical toward monitoring therapeutic agents and developing disease diagnostics. Yet drawing
insight on biomolecular events at such scales presents profound challenges to existing ﬂuorescence imaging.
Fundamentally, this arises due to the model selection problem: unavoidable (quantum, thermal, detector) noise
at the SM scale means that the data cannot easily be used to resolve “models" such as the number of molecules
located within a small region of space. An experimental solution toward resolving this problem earned the 2014
Chemistry Nobel prize though such solutions necessarily come at a cost. Either spatial or temporal resolution is
compromised while samples are often irradiated over extended durations inducing sample photodamage.
Recent Progress: Thanks to having reached the funding midpoint of both our NIGMS R01s, we developed
mathematical tools allowing us to mitigate, sometimes dramatically, spatial (R01GM130745) and temporal (R01
GM134426) compromises of existing experimental solutions to model selection. Our work has resulted in 10
publications, 15 collaborations, and 18 ongoing projects. Here are just 3 projects: 1) in recent publications,
we derived SM properties using 2-3 orders of magnitude fewer photons than would normally be used to obtain
bulk properties from ﬂuorescence correlation spectroscopy (FCS); 2) in accepted work, we provide a means
to determine protein cluster stoichiometry (up to hundreds of subunits) eliminating the requirement to control
ﬂuorescent label properties; 3) in work about to be submitted, we track with equal accuracy and precision about
an order of magnitude more labeled molecules as winners of the Nature Methods tracking competition.
Overview of Future Work: We've organized our future work as extensions of both R01's, projects merging both
R01's and directions beyond both. Brieﬂy, to extend existing R01's, we will: 1) provide the ﬁrst direct single-
photon analysis of single molecule ﬂuorescence resonant energy transfer (smFRET) data that simultaneously
learns the number of states of biomolecules even lifting the assumption of discrete states. We will apply this,
for example, to the unresolved rotational and translational dynamics of a transcription factor to DNA; 2) seek
computational solutions to aberration and illumination artifacts that can dramatically deteriorate our ability to
reliably track molecules intracellularly. In doing so, we will provide a computational alternative to adaptive optics
and apply our tools to the trafﬁcking and silencing activity of microRNAs often located deep within the cellular
nucleus. As we merge both R01's: we hope to track reaction-diffusion events of many molecules, resolved at the
SM level, and apply them toward understanding heterogeneous interactions of intrinsically disordered proteins.
Beyond both R01s: we will borrow Mathematics from SM to resolve the dynamics of a bacterial predator, a
candidate living antibiotic, as it hunts for its prey (E. coli) within the gut of c. elegans. Finally, we propose to
generalize refractive index (RI) mapping and structured illumination analyses currently limited to slow dynamics.

Public health relevance
Project Narrative At the intracellular level, life's events unfold at spatiotemporal scales whose direct observation presents pro- found challenges to ﬂuorescence-based imaging and spectroscopic methods. To unravel life's events at the single molecule level, current methods exploit specialized hardware, long data acquisition periods, and other techniques thereby stressing sensitive samples with light and often compromising either spatial or temporal resolution altogether. Here, instead, we propose novel mathematical tools to resolve biological events with minimal spatiotemporal compromise often using orders of magnitude less data on our way toward capturing reaction-diffusion of single interacting molecules from just thousands of recorded photons.